Regulation of rRNA transcription in mammalian tissues

Abstract / Project Summary
Ribosomal RNAs (rRNAs) comprise >80% of cellular RNA, and their transcription from rDNA repeats by RNA
Polymerase I (Pol I) accounts for a bulk of all transcription. The bodies of complex eukaryotes have different
ribosome production rates in different cell types. Precise control of rRNA transcription rates is important for
normal physiology, and its dysregulation leads to disease. However, though regulation of Pol II activity and the
transcription of mRNAs has been dissected in detail in virtually every organ system, the transcriptional control
of the most abundant RNA in the cell has been largely ignored, creating a fundamental knowledge gap.
Using MIRA R35 funding, we have created new bioinformatic and technical tools for mammalian rDNA and
rRNA studies, quantified rRNA transcription dynamics in a complex organ system, mapped ~2200 ChIP-Seq
tracks for ~250 transcription factors (TFs) and chromatin proteins to assemble a TF-rDNA atlas, demonstrated
that a cell-type-specific TF directly binds and regulates Pol I occupancy and rRNA transcription, and developed
a protocol to directly edit rDNA repeats. Our central hypothesis is that normal cellular identity and functioning
requires precise rRNA levels, fine-tuned in each cell type through a combination of control mechanisms. We
will interrogate this model in the next period of funding through the following projects:
PROJECT 1: Defining levels of rRNA regulation across cell types: We will use ChIP-Seq, FISH-Flow, and
metabolic labeling to quantify rRNA dynamics in defined primary mouse cell types in homeostatic and
stress-recovery states. The goal of this project will be to assemble a foundational map of the key steps in rRNA
transcription, processing, or lifespan that are differentially regulated across different mammalian cell types.
PROJECT 2: Testing the ‘Ribosome Concentration Hypothesis’: We will use a targeted degradation approach
to degrade Pol I and reduce rRNA transcription in a dose-dependent fashion, allowing us to achieve any
arbitrary ribosome number between 100% and 30% of normal. We will use this system to test the effects of
altered rRNA levels on selective mRNA translation and cell fates in cultured cells and in live animals.
PROJECT 3: Editing rDNA repeats to dissect promoters and regulatory regions: rDNA repeats have several
unique and poorly understood features, including the unusual structure of their promoters and a cluster of
cell-type-specific TFs whose conserved rDNA binding we recently identified. We will use Cas9-guided base
editors to systematically edit hundreds of rDNA repeats to dissect promoter sequences and TF motifs. Our
approach will rigorously test the model that the combinatorial binding of cell-type-specific TFs to regulatory
regions on rDNA controls Pol I occupancy and rRNA transcription in a cell-type-specific manner.
The long-term goal of this work is to gain a detailed understanding of how the universal process of rRNA
transcription has been customized to meet diverse tissue needs in complex organisms, a question of
fundamental importance to normal and disordered eukaryotic biology.

Public health relevance
Project Narrative Ribosomes are essential molecular machines that produce all proteins in the cell, and different cell types synthesize different numbers of ribosomes according to their varied needs. Precise control of ribosome production is important for cells to maintain normal functioning, but there is little understanding of how this process is controlled. This proposal seeks to use state-of-the-art molecular biology techniques to study ribosome production in mammalian cells, understanding both how the process is regulated and what the consequences are of its dysregulation.